National Community, Family, and Peer Support Core

Project Summary/Abstract - Leveraging Community, Peer, and Family Support Core
This Core facilitates research on and the development and evaluation of interventions addressing community,
peer, and family support. We define community as the overarching ecosystem through which family and peer
support is leveraged. Families and peers are defined broadly to include biological kin and individuals who
comprise current and potential new social networks. These may consist of colleagues, neighbors, participants
in a group medical visit, members of a virtual community, and even well-designed apps. Thus, this Core
emphasizes a) the exchanges within and between communities, families, and peers (i.e., overlap); b) the
characteristics and processes they share (i.e., interact); and c) the reciprocal association between their
influence and their contexts – culture, disease characteristics, stage of life, etc. (i.e., function). The Core will
support studies into these topics, including interventions anchored in communities and health care systems
that utilize community, peer, or family influences, broadly defined. To improve the design, implementation, and
evaluation of interventions, this Core will also support studies exploring community, peer, and family support
paths and how different contexts shape them.
The Core’s work is highly pertinent to the Center’s emphasis on anti-racism and health equity. It is important to
consider how communities, families, and peers are influenced by the harmful effects of racism and social and
economic injustice. At the same time, communities, peers, and families have critically important roles in helping
individuals confront racism and deal with its effects on their health and reducing inequity more broadly. This
Core’s objectives are centered on how supports from communities, peers, and families impact and can best be
mobilized to promote substantive positive changes in the lives and health of those affected by diabetes.
The Core is an outgrowth of the Michigan-UNC Peer Support Core, funded through the Michigan Center for
Diabetes Translational Research, 2016-21. It continues the Peer Support Core’s emphasis on the variety of
peers and peer support approaches and the processes that undergird them, while expanding on these to
include families and communities. With its national focus, the Core will serve colleagues at the University of
Michigan, the University of North Carolina-Chapel Hill, and diabetes researchers across the US. This will
include individual consultation to researchers and on research projects, national outreach, and facilitation such
as through webinars and annual research workshops of a national Special Interest Group of researchers
interested in the contributions of and interactions among community, peer, and family supports for reducing
inequity in diabetes prevention and management.